CLOMETHIAZOLE ACUTE STROKE STUDY IN ISCHEMIC STROKE

Intravenous administration of clomethiazole as a treament for stroke. Demonstrate the efficacy of clomethiazole compared to placebo on functional recovery measured on the barthel index when given to patients with an acute ischemic stroke.